Development and validation of efficient cognitive composite scores of digital tools for the detection of early pathophysiological changes in Alzheimers disease

PROJECT SUMMARY
Cognitive decline in preclinical Alzheimer’s disease (AD) has been closely correlated with tauopathy as
measured by Positron Emission Tomography (PET). Other pathophysiological factors (e.g., amyloid-beta and
neurovascular dysfunction) associated with cognitive decline contribute to the biological and clinical
heterogeneity in preclinical AD. Identifying this heterogeneity is crucial for improving the detection of preclinical
AD in cognitively normal (CN) individuals. Capturing pathophysiological events in preclinical AD has been
challenging with traditional pencil-and-paper cognitive assessments. Features of a cognitive digital clock
drawing test (dCDT) that capture time-stamped coordinates of drawing outcomes and process have
demonstrated superior correlations with tau PET in elderly CN subjects. However, the dCDT features used in
current studies were selected based on the clinical diagnosis between AD and CN subjects.
The overall goal of this project is to 1) identify novel dCDT features most correlated with underlying AD-
related pathophysiology measured using state-of-the-art multimodal neuroimaging techniques, accounting for
biological and clinical heterogeneity in preclinical AD, and 2) establish the longitudinal performance of dCDT in
capturing cognitive decline in preclinical AD. The identification of the novel dCDT features will provide a non-
invasive assessment of cognitive status in the context of progressive pathophysiological events in preclinical
AD. This will enable efficient and cost-effective participant screening for AD therapeutic trials, facilitate the
translation of digital testing into AD primary care settings, and in doing so, improve its access for underserved
populations. During the K99 phase, we will identify novel dCDT features most correlated with tau PET
measures using machine learning and deep learning. To accomplish these goals, the applicant will leverage
existing skills in PET imaging and machine learning and gain additional training in 1) multimodal neuroimaging,
2) deep learning, 3) pathophysiological, and 4) neuropsychological changes related to normal aging and AD.
With these training activities, the applicant will be well poised to conduct the R00 phase to evaluate the dCDT
performance in the context of clinical and biological heterogeneity in preclinical AD using multimodal
neuroimaging techniques. This award will facilitate the applicant’s transition to an independent researcher who
will utilize multimodal neuroimaging to better understand the biological mechanisms underlying brain disorders.

Public health relevance
PROJECT NARRATIVE In this project, the applicant will identify novel features of the digital clock drawing test most correlated with pathophysiological events in preclinical Alzheimer’s disease (AD) using machine learning and multimodal neuroimaging and establish the longitudinal performance of the digital test. Outcomes of the project will provide a non-invasive assessment of individual cognitive status in the context of progressive pathophysiological events in preclinical AD. This will enable efficient and cost-effective participant screening for AD therapeutic trials and facilitate the translation of digital testing into AD primary care settings, especially for underserved populations.